Administrative Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core provides the overall scientific leadership and management for the HNRC, with a primary
aim of ensuring integrated, coherent, and effective scientific operations. Within the Core, the Executive Team
provides programmatic leadership and oversight of the Center regarding resource allocation and future research
directions and projects. The decisions of the Executive Team are informed by both external and internal formal
review, advice and feedback. The external Scientific Advisory Board meets annually to evaluate Center progress
and to recommend future scientific directions. Internally, the Council of Investigators sets policy and closely
monitors scientific progress. Valued local input to the Executive Team also comes from the Community Advisors
(community providers, advocates, and leaders) and Participant Advisors (study participants). The leadership’s
key decision-making functions are implemented via four interacting components: the Coordinating Unit, which
has overall responsibility for executing and coordinating Center activities, including organizing the distribution of
Center resources, facilitating information dissemination to scientific and general communities, and ensuring
compliance with institutional and Federal policies; the Data Management and Informations System Unit, which
processes all Center-related data, ensures seamless interaction among Cores and associated projects, and
supports Center websites, videoconferencing, and mobile and online assessment applications; the Statistics
Unit, which provides statistical services at all study stages, from design to final analyses and manuscript
preparation; and the Participant Accrual and Retention Unit, which recruits cohorts of interest, maintains the
longitudinal cohort, and manages a registry of potential study participants. Each of these Units also engages in
methods development. In addition, strong working groups assist and guide the Core: the Research Review
Committee reviews requests for Center resources and serves as a venue for the discussion of current and
proposed studies and manuscripts; the HNRC Operations Workgroup, in which key managers and project
coordinators address project implementation and troubleshooting; and the Human Subjects Committee, which
monitors human subjects and Institutional Review Board issues, particularly relating to safeguarding
confidentiality. The structures and processes of the Core ensure the operation of a truly multidisciplinary research
center and foster a wide-ranging nimbleness and responsiveness, not only to priorities announced at the national
level by policy (e.g., the NIH) and those expressed by the national neuroHIV research community (e.g., our
nation-wide collaborating universities), but also within our home institution (e.g., HNRC scientific Core leaders,
other UCSD HIV research groups).